Administrative supplement for the purchase of a confocal microscope

Contact PD/PI: Mistriotis, Panagiotis
Summary: Cell migration is a fundamental cellular phenomenon that plays a pivotal role in (patho)physiological
events, including organ development, tissue regeneration and cancer metastasis. Our long-term goal is to
achieve a comprehensive understanding of the mechanisms of cell migration in order to develop novel
therapeutic tools and strategies to prevent the initiation and progression of diseases, including cardiovascular
pathologies, aging, and cancer. Building on the PI's postdoctoral work, the lab explores how the physical cues
of the local microenvironment (e.g., confinement, viscoelasticity, stiffness, pressure and shear stress) convert
into biochemical signals to influence the migratory behavior of cells. Over the next five years, we will employ
state-of-the-art microfabricated devices, materials, optogenetic tools, single-cell transcriptomics and
computational simulations to elucidate the effects of pressure forces on cell migration and viability. The scientific
premise of this application is based on prior studies showing that cells experience elevated pressure forces
during various stages of migration and invasion, including extra/intravasation and interstitial migration. Although
the widely held view is that cells can adapt to mechanical cues, an open and unaddressed question is how
elevated pressure affects cell behavior in diverse, yet physiologically relevant, microenvironments. To answer
this question, we will investigate the interplay between pressure forces and different microenvironmental cues
(physical or biochemical) in the regulation of cell migration. We will also assess whether long-term cell exposure
to high pressures alters the sensitivity of cell motility to physical cues. Last but not least, we will dissect the
relative roles and potential crosstalk between confinement and pressure in cell death regulation. Taken together,
the proposed studies, which are supported by highly encouraging preliminary results, will delineate the
underlying mechanisms regulating cell behavior in physiological environments and generate novel conceptual
information that will facilitate the identification of new therapeutic targets aimed at promoting or preventing cell
motility in vivo.
Project Summary/Abstract Page 6

Public health relevance
Contact PD/PI: Mistriotis, Panagiotis Project Narrative: Uncovering the molecular mechanisms controlling cell motility will facilitate the development of new therapeutic strategies aimed at enhancing the efficiency of stem cell therapies, promoting wound healing, or preventing diseases, including cancer metastasis. Although migrating cells can adapt to physical signals imposed by the local microenvironment, the impact of these cues on the mechanisms of cell locomotion remains unclear. We will herein employ an interdisciplinary approach to elucidate how pressure forces influence migration mechanisms and cell behavior in physiological microenvironments. Project Narrative Page 7